Genomic and Proteomic Analysis of Prion Synaptotoxicity

We have gathered strong evidence that the synaptotoxicity of prions depends on activation of specific signal transduction pathways that cause changes in protein phosphorylation mediated by key protein kinases, and that result in downstream alterations in gene transcription. In this project, we propose to use cutting-edge proteomic techniques and RNA-Seq to analyze global changes in protein phosphorylation and gene transcription in neurons undergoing the earliest detectable changes in synaptic structure and function. We will use specialized cultures of hippocampal neurons that respond rapidly (within hours) to neurotoxic forms of PrPSc by retraction of dendritic spines and by alterations in synaptic transmission. We then plan to process these data using sophisticated bioinformatics pipelines to identify cellular signaling pathways and transcriptional networks mediating the synaptotoxic effects of PrPSc. We anticipate that the comprehensive, discovery-based approach outlined here will yield important clues to the underlying biology of prion diseases, and will identify a wealth of novel therapeutic targets for ameliorating synaptic degeneration in these disorders.

Public health relevance
Prion diseases are fatal neurodegenerative disorders of humans and animals that pose a grave threat to public health, and endanger the safety of the food, blood and organ supplies. This grant proposal aims to use sophisticated genomic and proteomic techniques to identify the cellular pathways responsible for prion-induced damage to the synaptic connections between nerve cells. It is anticipated that the project will lead to identification of new molecular targets for treatment of prion diseases.